Dissecting how rapid microbial pathogen containment occurs in vivo

Abstract
Inflammatory Ly6C+ monocytes are a subset of highly plastic myeloid cells that are rapidly mobilized during
multiple types of microbial pathogen infections (bacteria, virus, fungi, parasites) and differentiate into robust
microbicidal effector cells that can secrete TNF and produce nitric oxide and reactive oxygen species directly
contributing to pathogen killing and elimination. We and others have also reported that Ly6C+ monocytes
accumulate and form clusters at foci of microbial pathogen infections. In recent work using mice infected with
the intracellular bacterium Listeria monocytogenes and intravital multi-photon imaging, we also revealed that
Ly6C+ monocytes arrest at infection foci, exhibit a highly activated phenotype and deliver local effector
functions. While it is well established that these cells egress from the bone marrow to the blood via CCR2 in
response to the rapid release of CCL2 that occurs upon microbial product sensing, how they reach infected
tissues, home to foci of infections and form stable clusters is still largely unknown. Many chemotactic and
adhesion mechanisms have been ruled out to regulate these processes, suggesting either other mechanisms
or redundancy. Here we formally test the hypothesis that Ly6C+ monocytes need to home to foci of infection
and form stable clusters to deliver local and powerful effector functions to help clear pathogens. This
exploratory proposal will define the chemotactic cues and receptors involved, the initiating and orchestrating
target cells that orchestrate Ly6C+ monocytes homing to infection foci and the molecules involved in monocyte
arrest and formation of stable clusters. We will use combinations of genetic gain and loss of function
experiments in vivo, bacterial, parasitic and viral infection models, cutting-edge intravital microscopy imaging
and in vitro functional chemotactic assays.

Public health relevance
Public Health relevant statement This project has the potential to improve antimicrobial immunity. Specifically, the proposal focuses on populations of white blood cells (leukocytes), namely monocytes, that are mobilized from the bone marrow to infected tissues during microbial pathogen infections (bacteria, virus, fungi, parasites). These cells can quickly express multiple functions that are important to protect the host against infectious microbes during initial infection but also during a second infection of vaccinated hosts. We studied how these cells protect vaccinated host by very precisely delivering their microbicidal killing functions at sites of microbial pathogen growth, resulting in rapid pathogen control and elimination from the host. We propose here to understand how these cells rapidly reach infectious foci and deliver killing effector activities leading to the efficient elimination of invading microbial pathogens in vivo with the ultimate goal of designing novel immune therapies.